Introducing NanoProTEN, a novel approach for anticoagulation in patients with prothrombotic autoantibodies

Project summary
This project aims to investigate a novel approach to mitigate the risk of vascular thromboses, which imposes a
significant economic burden in the US. Our strategy is to develop a technology that, by specifically targeting the
lipid-binding domains of factor X (read factor ten) and prothrombin, two essential coagulation factors, regulates
the rate at which factor Xa and thrombin are produced and, consequently, controls the formation of blood clots.
This approach is unique compared to current pharmacologic methods that either directly (DOACs) or indirectly
(heparins) target the active site of clotting proteases or impair the proper synthesis of a family of proteins to
which multiple coagulation factors belong (warfarin). We propose this approach will offer potential benefits for
patients with prothrombotic antiphospholipid antibodies who experience limited effectiveness with existing
medications. Antiphospholipid antibodies are a defining feature of antiphospholipid syndrome (APS), which is an
acquired autoimmune disorder. Additionally, there is evidence of their involvement in infectious diseases,
including COVID-19. By using an in vitro selection process, our preliminary studies identified a nanobody suitable
for testing this hypothesis, which we called NanoProTEN. Aim 1 of this project aims to investigate the biochemical
characteristics of NanoProTEN, including its affinity and specificity towards coagulation factors and plasma
proteins involved in the blood clotting cascade. We will then assess its anticoagulant potential in human plasma
and with purified coagulation factors, and its ability to interfere with antiphospholipid antibodies. These studies
will define the molecular interactions of NanoProTEN, evaluate its potential off-target effects, and establish its
anticoagulant potential compared to existing therapies. Studies in Aim 2 will define the unique mechanism of
action of NanoProTEN through structural studies using cryo-electron microscopy. By determining the structures
of NanoProTEN bound to prothrombin and factor X, we will uncover the structural elements contributing to its
dual selectivity. These studies will determine how NanoProTEN interacts with these factors, offering mechanistic
insights into its mode of action and providing essential information for enhancing its activity. In conclusion, the
primary outcome of this research project is the development of an innovative technology represented by
NanoProTEN. This technology holds promise as a versatile research tool and a potential candidate for a new
class of anticoagulants for improving outcomes in patients with prothrombotic autoantibodies and potentially
other thrombotic disorders.

Public health relevance
Project narrative Antiphospholipid antibodies can elevate the risk of blood clot formation. Unfortunately, existing treatment options in individuals with antiphospholipid antibodies have demonstrated limited effectiveness, as evidenced in antiphospholipid syndrome patients. This project introduces a novel approach that involves dual targeting of two essential coagulation factors to mitigate the risk of vascular thrombosis in individuals with prothrombotic autoantibodies.